Next Generation Pediatric Neuroimaging (NGPN) Development

Pediatric MR imaging is especially difficult due to motion-related artifacts in the images. Often
this requires general anesthesia in the clinic, which has been shown recently to be
detrimental to brain development. This places unique barriers on assessment of this
population for both clinical and research purposes. In this application, we propose the
development of the Next Generation Pediatric Neuroimaging (NGPN) technology, which will
allow for high quality MR images to be collected in the presence of motion, thereby
eliminating the need for general anesthesia while imaging. This technology will provide the
MRI contrasts for proton density, T1, T2, T2*, diffusion, perfusion, and fMRI. The NGPN will
be achieved by the development of novel hardware (RF coils and T/R switches), imaging
sequences, and image reconstruction tools. These advancements will allow clinicians and
researchers to image pediatric subjects in a safer, more reliable and efficient manner.

Public health relevance
The project will make new tools for magnetic resonance imaging of children. It will help make the scan quieter and correct for movement if the child cannot keep their head still. This will make it easier for children to participate in brain research and eventually lead to quicker and safer scans at the hospital or clinic.